Rapid inter-procedural 3D scanning of fine-needle aspiration cytology slides with a parallelized microscope

Significance: Fine needle aspiration (FNA) biopsies are a critical first step in the cancer diagnosis
pipeline, wherein specimen material is extracted from a suspected pathological lesion and smeared onto
a microscope slide. Cytopathologists then examine three-dimensional groups of cells across the entire
slide for diagnostic purposes. Ideally, a cytopathologist is available in-person to perform “rapid on-site
evaluation” (ROSE) during such FNA biopsy procedures, like bronchoscopies, which is known to increase
positive predictive value and decreases procedure time for cancer diagnosis. Unfortunately, relatively
few cytotechnologists and pathologists are available to perform ROSE, most notably outside of large
hospital settings. Without ROSE, proceduralists generally do not know if they have obtained adequate
specimen material for diagnostic review, or how to triage such samples, which leads to additional patient
visits, additional procedures, and increased risk of side effect and harm.
Proposal: In this project, Ramona Optics and the Duke Medical Center aim to develop a new imaging
system, termed a multi-camera array scanner (MCAS), that rapidly digitizes and automatically analyzes
thick FNA cytology smears in 3D. The MCAS will provide real-time (<1 min.) diagnostic feedback
regarding specimen adequacy and diagnostic category (e.g., malignant or benign) during FNA biopsy
procedures, such as to bronchoscopies, which can assist in scenarios where cytopathologists are not
available for in-person specimen review. In this proposal, we aim to show how the MCAS’s automated
inter-procedural analysis of FNA cytology can empower clinicians with valuable insights in real-time.
Apart from empowering clinicians like bronchoscopists, we believe the MCAS can increase health equity,
improve FNA biopsy procedure success, and help inform optimal next steps within the care pipeline.
SA1 - Enhance MCAS scanning speed and algorithm accuracy: We will develop rapid focusing hardware,
fast data transfer firmware and novel image screening software to ensure MCAS 3D scan and analysis
speed is performed on whole-slide FNA cytology smears in < 1 min. for inter-procedural use.
SA2 – Develop software for automated adequacy assessment and diagnostics: In collaboration with Duke
Medical Center, we will scan 500 archival lung FNA cytology smears and train 3 unique machine learning
algorithms to automatically assess 1) specimen adequacy, 2) malignancy, and 3) diagnostic category.
Software will also display images of salient FNA specimen areas for a transparent review process.
SA3 - Develop MCAS user interface and perform clinician-focused testing: In a final series of user tests
with 6 clinicians at the Duke Medical Center, we aim to obtain direct feedback regarding MCAS hardware
and software for automated and remote ROSE during simulated bronchoscopies, which will guide future
development and clinical testing during bronchoscopy procedures within a planned Phase II project.

Public health relevance
The visual examination of fine needle aspiration (FNA) cytology specimens by a pathologist is a common first step in the cancer diagnosis pipeline that is ideally performed during biopsy procedures, via a process termed rapid on-site evaluation (ROSE). In this project, Ramona Optics and Duke University aim to develop and test a new multi-camera array scanner that rapidly images and digitally analyzes entire FNA cytology smears in 3D (18 cm2 area, 50 µm thick, <1 µm resolution) to provide proceduralists with rapid feedback regarding specimen contents (in < 1 min.). We aim to demonstrate how the MCAS’s automated ROSE results can empower proceduralists to take additional steps towards effective care in real-time to improve FNA biopsy success and help inform optimal next steps within the care pipeline. .